Programming of Monocyte and Macrophage Populations by Early-Life Glucocorticoid Exposure

PROJECT SUMMARY
Exposure
such
pituitary-adrenal
(GC)
been
GC
macrophages
to adverse environments early in l ife is associate d with prevalent inflammatory human pathologies
as inflammatory bowel disease, obesity, and diabetes, as well as allergies and asthma. The hypothalamic-
(HPA) axis is a crucial stress response pathway that regulates the production of glucocorticoids
i n response to diverse environmental stressors Notably, dysregulation of the HPA axis and GC levels has
strongly correlated with morbidities associated with early-life stress exposure. However, how heightened
activity early in life leads to short and potentially long-term functional alterations in monocytes and
to promote the development of prevalent human pathologies remains poorly understood. Hence,
.
the overarching goal of this proposal is to investigate the mechanisms through which two prevalent conditions in
children, psychological stress and diet-induced obesity (DIO), reprogram the functions of monocyte and
macrophage populations in response to elevated GC levels, leading to short and potentially long-term
susceptibility to enhanced inflammatory and metabolic disease progression. In the first aim of this proposal,
we will elucidate how GC regulate monocyte populations in the gastrointestinal tract in response to early life
exposure to psychological stress. Our preliminary data indicate that GC induced by early-life stress promotes
the emergence of an inflammatory subset of enteric glial cells characterized by the expression of Nur
transcription factors (TF), which in turn induce intestinal inflammation through the recruitment of TNF-
expressing monocytes. We now propose to use genomics and novel mouse genetic tools to uncover how stress-
induced GC early in life promote the emergence of inflammatory glia as well as the reprogramming of their
chromatin landscape. Moreover, we will establish the mechanisms by which this novel glial cell subset remodels
intestinal monocyte populations to promote intestinal inflammation in juvenile and potentially adult organisms. In
the second aim of this proposal, we will determine how GC regulate macrophage populations in epididymal
white adipose tissue (eWAT) during early-life obesity. Using a single-cell RNA sequencing atlas of early-life DIO
that we generated, we identified a novel subset of eWAT macrophages exclusively found in juvenile obese mice.
This macrophage subset has a striking GC signaling signature which includes the expression of the TF KLF9
and the growth factor IGF-1, both of which have been associated with increased susceptibility to obesity. We
now propose to establish how GC induced during early-life obesity promote the emergence of this novel eWAT
macrophage subset as well as the reprogramming of their chromatin landscape. Furthermore, we will establish
the mechanisms by which this macrophage subset regulates eWAT function through the secretion of IGF-1.
Collectively, these studies will answer the long-standing question of how GC induced by adverse environments
early in life promote short and potentially long-term functional alterations to myeloid cell populations in multiple
tissues, and reveal new insights into deleterious consequences of chronic exposure to these therapeutic agents.

Public health relevance
PROJECT NARRATIVE Early-life such remain induced alterations organism transcriptional, directly exposure to adverse environments s associated with multiple childhood and adult-onset disorders, as obesity, diabetes, and inflammatory bowel disease, but the mechanisms underlying this association incompletely understood. The overarching goal of this proposal is to decipher how glucocorticoids by early-life stress and diet-induced obesity induce short and potentially long-lasting functional in monocyte and macrophage populations in intestinal and adipose tissues, which predisposes the to exacerbated intestinal inflammation and obesity-associated disorders. Our studies will uncover the epigenetic, and functional mechanisms by which chronic glucocorticoid signaling early in life, and indirectly, reprograms myeloid cell biology across different tissues and environmental stressors. i